Inhibition of tyrosine kinase Fgr mitigates hematopoietic acute radiation syndrome (H-ARS)

Mass exposure to total body irradiation (TBI) could occur from a nuclear accident or nuclear attack. Ionizing
radiation (IR) causes inflammation and acute damage to both hematopoietic (H) and gastrointestinal (GI)
systems [1-2]. The bone marrow damage due to radiation exposure is known as the acute hematopoietic
radiation syndrome (H-ARS) [3]. FDA approved drugs to H-ARS are mostly recombinant growth factors such as
G-CSF that do not seek to address the root cause of inflammation [4-5]. Therefore, there is an urgent need for
novel medical countermeasures (MCMs) that will target master regulators of inflammation, proliferation, and
tissue regeneration in response to TBI injury [6]. We have discovered that Fgr, a non-receptor tyrosine kinase,
is the master regulator of bone marrow (BM) inflammation following TBI, and Fgr inhibitor TL02-59 is a novel
mitigator of H-ARS. In preliminary experiments we found 1) Significant increase in Fgr expression in irradiated
mouse BM cells. We have verified this result in non-human primate (NHP) bone marrow cells following TBI, in
collaboration with Dr. Mark Cline’s laboratory, at the Wake Forest University. 2) Significant improvement in BM
cellularity, and dramatic improvement in survival of irradiated Fgr-knockout mice, and of mice that receive the
Fgr-inhibitor TL02-59. 3) Increase in pro-hematopoietic proteins including G-CSF, GM-CSF, and reduction of
inflammatory proteins in the BM of Fgr-/- mice, 4) The Fgr-/- BM is more radioresistant measured in an assay for
multilineage hematopoietic cells and increased CFU-GEMM colonies. 5) Fgr inhibitor TL02-59 reduces secretion
of inflammatory proteins from irradiated BM stromal cells. We hypothesize that Fgr is a master regulator of bone
marrow inflammation, which leads to BM failure, and absence of Fgr mitigates radiation-induced inflammatory
damage. We will establish that induction of Fgr as a key detrimental event in inducing BMF in the hematopoietic
microenvironment. Using mouse and non-human primate models of BMF induced by total body irradiation and
administering Fgr inhibitor TL02-59 in mice, we will establish that Fgr tyrosine kinase is a master regulator of
bone marrow inflammation leading to H-ARS. In Aim 1, We will Establish that tyrosine kinase Fgr plays a key
role in BM inflammation that precedes H-ARS demonstrating that ionizing radiation exposure leads to induction
of Fgr in specific BM cell phenotypes in mouse and in non-human primates. Using inducible Fgr knockout mice,
we will prove that removal of H-ARS leads to upregulation of pro-hematopoietic proteins, and suppression of
inflammatory proteins. In Aim 2, we will determine that ablation or inhibition of Fgr by TL02-59 mitigates H-ARS
in TBI treated mice, and mice with BM specific knockout of Fgr. We will establish that inhibition of Fgr using a
small molecule inhibitor mitigates radiation induced bone marrow inflammation. Successful completion of the
experiments proposed in the Aims will lead to the discovery of a most potent mitigator of H-ARS yet reported.
Moreover, by addressing the root cause of inflammation, the Fgr inhibitor treatment will lead to a complete
mitigation of H-ARS at 24 h after TBI.

Public health relevance
Ionizing radiation causes inflammation and acute damage to both hematopoietic (H) and gastrointestinal (GI) systems and the bone marrow damage due to radiation exposure is known as the acute hematopoietic radiation syndrome (H-ARS). We have discovered that Fgr, a non- receptor tyrosine kinase, is the master regulator of bone marrow (BM) inflammation and is induced following TBI. We propose to demonstrate that inhibition of Fgr by TL02-59 will mitigate H-ARS, and lead to the discovery of a most potent mitigator of H-ARS yet reported.